NCI National Clinical Trials Network - Network Lead Academic Participating Sites (UG1)

Project Summary/Abstract
Norris Cotton Cancer Center (NCCC), the keystone of the cancer-related activities of both
Dartmouth College, including its Geisel School of Medicine, and Dartmouth-Hitchcock Health,
will participate in the NCI's National Clinical Trials Network as a Lead Academic Participating
Site. NCCC has a long history of leadership in national cooperative group clinical trials, dating
back to serving as an operating center for CALGB, and more recently as a main member of the
Alliance for Clinical Trial in Oncology, NRG, COG, and ECOG/ACRIN. As the only NCI-
designated Comprehensive Cancer Center in northern New England, NCCC currently serves
annually over 5,000 new patients and 30,000 returning cancer patients. NCCC is the specialty
academic center for Vermont and New Hampshire, anchoring a network of 17 community-based
practice sites across the region and receiving referrals of rare and advanced cancers, the target
population for enrollment on innovative clinical trials, from a large geographic catchment area.
Within Dartmouth, NCCC has a central Office of Clinical Research (OCR) which coordinates full
participation in the entire range of available clinical trials. NCCC intends to participate fully in all
NCTN activities, expanding its prior focus on participation in the Alliance. NCCC investigators
are active in many NCTN Operations Center committees, facilitating a bi-directional integration
of NCCC concepts into the NCTN, while NCTN studies will be seamless incorporated into the
NCCC trial portfolio. We anticipate accrual of 55 consented subjects on high performance
intervention for treatment trials and 20 subjects on screening only accruals for treatment or
imaging trials. Care at DH is organized into 17 designated interdisciplinary disease-based
teams which bring together all relevant specialties, 14 on a weekly basis, for new patient
conferences at which eligibility for enrollment on clinical trials is assessed routinely. NCCC
research nurses assigned to these Clinical Oncology Groups (COGs) are responsible for
keeping the teams informed of available trials, and the NCCC clinical trials management system
(Velos eResearch) provides the teams reports tracking current enrollment. While highest
priority is given to translating NCCC science into clinical application, Dartmouth's size precludes
most single-institution studies, and national cooperative group trials are prioritized ahead of
industry-initiated studies for fulfillment of NCCC's clinical research mission.

Public health relevance
Narrative Dartmouth-Hitchcock Health is the leading specialty care network for a vast geographic region covering New Hampshire and Vermont statewide. The Norris Cotton Cancer Center (NCCC) is the academic hub for services for rare and advanced cancer cases across the region. As a Lead Academic Participating Site in the National Cancer Institute’s National Clinical Trials Network, our overarching mission is to advance the NCTN collaborative clinical research program of definitive clinical trials, including multi-modality, umbrella/basket, and rare tumor trials, and to translate basic science studies into meaningful advancements in the care of Northern New England cancer patients.